Exploiting cell fate transition to overcome radiation resistance in glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is a devastating brain tumor that affects about 15,000 Americans every year. Despite
maximal surgical resection and chemoradiation, GBMs remain incurable. GBMs are notoriously radiation
resistant. Molecular subtyping of GBMs by genomic analyses of patient tumors identified three major subtypes,
termed Proneural (PN), Classical or Mesenchymal (MES), based on gene expression patterns. Collaborative
efforts between the Sulman and Bhat laboratories over the years has uncovered glioma stem-like cells (GSCs)
closely resembling molecular subtypes of GBM. These states, however, exhibit plasticity and we pioneered the
notion of PN to MES transition based on studies using patient derived GSCs linking MES signatures with radio-
resistance and identifying master transcription factors associated with the MES subtype. New exciting
preliminary data from our laboratories have identified three independent molecular targets associated with
radiation resistance. Using whole-genome CRISPR screens to identify gene targets associated with enhanced
radiation sensitivity as well as and mass spectrometric evaluation of radiation induced protein complexes, we
have uncovered three players involved in metabolic, epigenetic and DNA repair pathways that can be targeted
to overcome radiation resistance in GSCs. The overall goal of this proposal is to combine these druggable targets
with the standard use of fractionated photon radiation therapy (RT) and convert GSCs from radioresistant to
radiosensitive. In Aim 1, we will examine if inhibition of N-acylneuraminate-9-phosphatase (NANP) will lead to
radiosensitization of GBM transitioning from MES to PN states via metabolic reprogramming. In Aim 2, we will
test if targeting High Mobility Group Box-2 (HMGB2) leads to a block of MES transitioning and alterations of
chromatin and if it is lethal in combination with radiation. Finally, in Aim 3, we will examine the radiosensitizing
effects of neuronal differentiation with combined TAZ inhibitors and ionizing radiation in pre-clinical models of
GBM. Our proposal is significant because this is the first comprehensive study to examine the radiosensitizing
effects of cell state transition blockade in GBM. Data generated from this grant will encompass TCGA datasets,
patient derived GSCs, clinically relevant xenograft models as well as testing of inhibitors in these models with a
trajectory toward Phase I clinical trials to overcome radioresistance in patients with GBM.

Public health relevance
PROJECT NARRATIVE Glioblastomas (GBM) are the most recalcitrant adult brain tumors affecting about 15,000 Americans every year and exhibit considerable resistance to chemo and radiation therapy. In this proposal, we have identified novel modulators of radiation resistance and propose to use synthetic combinations to target these pathways and sensitize glioma cells to radiation. The overall goal is to use these pre-clinical studies to design new and effective treatment options for patients with GBM.